Experimental and preclinical modeling of NUP98-rearranged acute leukemia

Project Summary
The overarching goals of the original FusOnC2 consortium award titled Experimental and Preclinical Modeling
of NUP98-rearranged Acute Leukemia are to understand the mechanistic basis of NUP98 FO-driven
leukemogenesis and to develop and translate new, more effective therapeutic approaches for this form of
leukemia. Work in Project 1 of this consortium seeks to develop and characterize more faithful experimental
models of NUP98-rearranged leukemia and leverage these models to improve our understanding of the biology
and potential therapeutic targeting of this high-risk subset of acute leukemias. In this application, we propose
the use of integrated cell barcoding and multi-omic single-cell sequencing in mouse and human models of
NUP98-rearranged leukemia to dissect how NUP98 FO, cell-of-origin, and transcriptional dysregulation intersect
to drive leukemogenesis and leukemia cell phenotype. The proposed research is complimentary to but not
overlapping with our currently funded projects. Additionally, it will provide interactive collaborations with Drs.
Shalin Naik and Mark Dawson, as well as with members of their research groups, who have previously used
lineage tracing to study hematopoietic development and malignancy. To achieve the goals of this complimentary
supplemental application, we propose the following specific aims:
Aim 1: To identify the gene expression profile, chromatin accessibility landscape, and immunophenotype of
mouse HSPCs permissive to NUP98 FO-driven leukemia. Here, we will obtain single-cell profiling and lineage
tracing (SPLINTR) barcoding libraries from our collaborators, and optimize their use in mouse hematopoietic
stem and progenitor cells (HSPCs). We will then leverage penetrant mouse models of NUP98::KDM5A and
NUP98::LNP1 fusion oncoproteins (FOs), which have been developed in the Mullighan and Klco laboratories,
and combine SPLINTR barcodes with empty vector, NUP98::KDM5A, or NUP98::LNP1 FO. FO+barcode+ cells
will be profiled under in vitro conditions as well as after transplantation and leukemia development in vivo.
Samples will be subjected to multi-omic single-cell profiling (DOGMA-seq) before and after the introduction of
FO to identify changes in gene expression, chromatin accessibility, and immunophenotype driven by NUP98
rearrangement. Furthermore, single-cell sequencing of bone marrow and spleen samples from leukemic mice
will allow us to assess the gene regulatory state and stem cell/progenitor subtypes permissive to leukemogenesis
in vivo.
Aim 2: To characterize the differentiation and gene regulation patterns induced by NUP98 FOs in conditions
suitable for multilineage human hematopoiesis. In this aim, we will apply SPLINTR barcoding to human models
of NUP98 rearrangement. SPLINTR barcodes will be introduced in cord blood CD34+ HSPCs, which will
subsequently be transduced to express empty vector, NUP98::KDM5A, or NUP98::LNP1. Cells will be exposed
to in vitro conditions suitable for multilineage hematopoiesis, and changes in gene expression, chromatin
accessibility, and immunophenotype will be determined via DOGMA-seq to identify the effect of FO expression
on gene regulation and differentiation. Furthermore, we will perform similar studies followed by transplantation
of FO+barcode+ CD34+ cells into immunodeficient mice. These studies will provide insights on the FO-induced
changes that occur in vivo and compare them with the results we observe in in vitro, in mouse models (Aim 1),
and in NUP98-rearranged patient samples.

Public health relevance
Relevance Using integrated cell barcoding and multi-omic single-cell sequencing in primary hematopoietic cells expressing NUP98 fusion oncoproteins, as proposed here, will accelerate the goals of the FusOnC2 consortium by enhancing our understanding of the genetic and non-genetic factors contributing to NUP98-rearranged leukemogenesis. Our experiments will dissect the relationship between cell-of-origin, transcriptomic/chromatin perturbations and leukemia lineage in mouse and human models of NUP98 rearrangement. In doing so, the proposed studies will reveal the cell-of-origin for NUP98 FO-driven hematologic malignancies, which has not been previously reported. Furthermore, the experiments described in this application will provide deeper insights into the biology of NUP98-rearranged disease and will provide additional models for therapeutic exploitation, which we expect will compliment and further the overall goals of the FusOnC2 community.